Acquisition and Consolidation of Contextual Fear Memory in Engram Cell Pathways

PROJECT SUMMARY/ABSTRACT
In order to survive, animals develop fear responses to dangerous situations. The neural mechanism of
learned fear has great survival value for animals, who must predict danger from seemingly neutral contexts. For
adaptive fear, the brain discriminates between different contexts and associates only relevant contexts with
aversive events. Dysregulation of this process leads to maladaptive overgeneralized fear in PTSD, which affects
7 percent of the U.S. population. A fundamental gap in understanding the mechanism underlying the specificity
and persistence of contextual fear memory limits research on developing effective neuromodulatory strategies
to prevent long-lasting maladaptive fear in PTSD. The overall objective in this application is to determine the
mechanism by which specific contextual fear memory is encoded and consolidated in a network of the
hippocampus, neocortex, and amygdala. The rationale for the proposed studies is to fill a critical void in the
understanding of fundamental principles of adaptive fear responses to relevant contexts and to provide new
insight into developing strategies to attenuate persistent pathological fear in PTSD. The central hypothesis,
based on the applicant’s preliminary data, is that (1) the acquisition and consolidation of contextual fear memory
require strengthening of engram cell pathways, which connect populations of memory engram cells in a
distributed network, and (2) selective weakening of the engram cell pathways prevents conditioned fear
responses to a context that predicts danger. This hypothesis will be tested by pursuing three specific aims: (A)
Determine how contextual fear memory is encoded in the hippocampal–amygdala circuit and how it is
consolidated for permanent storage in prefrontal neocortical circuits (Aims 1 and 2), and (B) Determine input-
output connectivity of memory engram cells for contextual fear memory (Aim 3). The first and second aims will
investigate synaptic changes in the context-specific hippocampal–amygdala pathway as well as excitatory
connections between prefrontal neocortical engram cells during the acquisition and consolidation of contextual
fear memory. To accomplish this, the applicant recently developed a novel approach by combining engram cells
labeling, optogenetic, and electrophysiological techniques. Under the third aim, engram cells labeling and trans-
synaptic tracing will be used to determine how memory engram cells are connected to neurons conveying
contextual and aversive signals and neurons generating defensive behavior. The proposed research is
innovative because it will use novel combined approaches to efficiently identify the neural correlates of
associative memory encoded in functionally heterogeneous neural circuits, which has been unattainable through
conventional approaches. The proposed research is significant because it will elucidate how fear memory for a
relevant context is encoded and consolidated in a distributed network of memory engram cells and provide
insight into developing a novel approach to attenuate chronic maladaptive fear in PTSD without affecting
adaptive emotional memories.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of fundamental principles of fear memory specificity and persistence is ultimately expected to increase the understanding of the pathogenic mechanism of chronic overgeneralized fear in post-traumatic stress disorder and provide insights into developing novel therapeutic approaches to prevent long-lasting maladaptive fear. The project is relevant to the part of NIMH’s mission that pertains to developing fundamental knowledge that will transform the understanding and treatment of mental illnesses.